Individually targeted neuromodulation for contamination-based OCD

PROJECT SUMMARY/ABSTRACT
The symptoms of obsessive-compulsive disorder (OCD) appear linked to dysfunction in a cortico-striato-
thalamo-cortical circuit. However, obsessions and compulsions vary widely among OCD patients, suggesting
that other symptom-specific brain networks may accompany this core defect. Identifying such networks could
lead to individualized treatments, improving upon current “one size fits all” approaches. Factor analyses have
found distinct symptom dimensions in OCD, but the neural systems specific to these dimensions remain
unclear. Using a novel individual-level approach to resting-state functional connectivity magnetic resonance
imaging (fcMRI), we have shown that increased connectivity between right medial frontal gyrus (R MFG) and
brain regions within the ventral attention network (VAN) – regions critical to reorienting attention in response to
relevant external stimuli – specifically predicted the severity of contamination/washing (CONTAM) symptoms,
and attenuation of this hyperconnectivity following treatment was associated with improvement in CONTAM
symptoms. Based on these findings, we hypothesize that decreasing R MFG-VAN connectivity via transcanial
magnetic stimulation (TMS) will normalize attentional reorienting and reduce CONTAM symptoms in individuals
with contamination-based OCD. Therefore, consistent with the R61/R33 mechanism, we propose a two-phase
program to investigate R MFG-targeted TMS as a potential intervention for contamination-based OCD. In the
R61 phase, we will determine the optimal TMS paradigm to decrease R MFG-VAN connectivity by
administering both continuous and intermittent theta burst stimulation (cTBS, iTBS) to individuals with
contamination-based OCD using a novel individual-level approach to target the area of R MFG most strongly
correlated with VAN based on each participant's pre-treatment connectivity data. If successful, we will proceed
to the R33 phase in which we will use the TMS approach identified in the R61 phase to test the links between
reduced R MFG-VAN connectivity, decreased VAN activation during attentional reorienting, and reduced
CONTAM symptoms in a larger sample of OCD individuals with CONTAM. This project will yield several major
advances. First, it will demonstrate a causal link between R MFG-VAN hyperconnectivity and CONTAM
symptoms. Second, it will confirm that R MFG-VAN hyperconnectivity is a viable treatment target for
contamination-based OCD, and demonstrate that decreasing R MFG-VAN connectivity leads to normalized
attentional reorienting and reduced CONTAM symptoms. Third, it will provide initial evidence for R MFG-
targeted TMS as a treatment for contamination-based OCD. Collectively, this work will be the first of its kind to
identify a dimension-specific cortical target for neuromodulation in OCD, thus making a major advance toward
precision medicine for this disorder, and highlighting the future application of this innovative research program
to identify neuromodulatory targets for additional OCD symptom dimensions.

Public health relevance
PROJECT NARRATIVE Patients with obsessive-compulsive disorder (OCD) experience a wide array of different types of obsessions and compulsions. However, current treatments for OCD employ a “one size fits all” approach and are used for all patients regardless of symptom type. In this project, we propose to investigate whether a novel method of transcranial magnetic stimulation specifically reduces contamination/washing symptoms – one of the most common types of OCD.